Impact of RPS15 mutation on development and progression of chronic lymphocytic leukemia

Project Summary/Abstract There is mounting evidence that ribosomes are more dynamic and heterogenous than previously described. Advances in our understanding of ribosomal functions now paint a picture of ribosomes as critical regulators of gene expression with unique compositions and highly specialized functions that can differ across tissue types. Aberrant ribosome activity has been assessed in many tumor types and recurrent mutations in ribosomal proteins have been reported in a number of cancers and ribosomopathies associated with cancer, such as T-ALL and Diamond-Blackfan anemia. This can include changes in the fidelity and rate of translation, preferential translation of certain transcripts over others, utilization of alternative start and stop codons, and overall changes in intra- cellular ribosome content. Recent whole exome sequencing studies of 538 patients with chronic lymphocytic leukemia (CLL) have identified recurrent missense mutations (~5%) at a hotspot region of ribosomal protein S15 (RPS15). RPS15 mutations often co-occur with TP53 aberrations (36%) and are enriched in del(17p) CLL (12%) — abnormalities that are often carry poor prognoses and refractoriness to chemoimmunotherapy. Indeed, mutation of RPS15 is associated with adverse prognosis and an increased risk of relapse following chemo- immunotherapy, even in the absence of TP53 or del(17p) deletions. However, despite these compelling clinical findings, there is a paucity of information regarding how RPS15 mutation influences CLL pathogenesis. We have generated an array of unique tools for the proposed study of this essential protein that promise to unravel this mechanism. This includes human CLL cell lines that are well characterized and carry genetic mutations that reflect common CLL lesions, such as del(13q) and TP53, and that have been edited to express RPS15 mutations relevant in CLL. We have also generated physiologically faithful Rps15 knock-in mice that restrict mutant expression to B cells. Using these models to characterize the functional impact of this mutation on CLL development and progression will certainly provide new directions for therapeutic intervention and will add to our fundamental understanding of ribosome pathology. The proposed study seeks to thoroughly interrogate the impact of RPS15 mutations on CLL biology through the following aims: 1) Characterize its influence on ribosomal protein functions (such as ribosomal RNA synthesis, ribosome assembly, translation and extra-ribosomal functions — namely, the MDM2-P53 ribosome surveillance pathway) in both healthy and malignant tissue; and 2) Determine its impact on cancer hallmarks such as proliferation and growth factor independence in vitro and on tumorigenicity in vivo. Because RPS15 mutations engage the mRNA decoding site, we hypothesize that they contribute to pathogenesis through aberrant translation of mRNA. The proposed experimental approaches include complex and novel techniques such as ribosome characterization, ribosome profiling, FISH, ribosomal RNA characterization through northern blotting, and tumorigenicity studies using in vitro and in vivo CLL models.

Public health relevance
Project Narrative Chronic lymphocytic leukemia (CLL), the most common leukemia in adults, is a highly variable disease in terms of genetics and clinical outcomes. Advances in next generation sequencing technologies have led to the discovery of novel mutations in CLL, including RPS15, a ribosomal protein that when mutated associates with poorer prognosis and an increased resistance to therapy. Understanding the impact of this mutation on the development and progression of CLL will contribute to our understanding of ribosome pathology in cancer and its influence on drug resistance, allowing for the future development of more targeted and effective therapies in this patient population.